Simulation Analyses to Optimize Workplace Social Network Interventions for Improving Health Behaviors in Midlife

ABSTRACT
Modifiable risk factors, including diet quality, have a significant impact on disability and life expectancy. Social
network analyses demonstrate that social connections play a role in initiating and reinforcing these risk factors
through mechanisms such as mutual support and information exchange, as well as social influence pathways
like modeling, the establishment of social norms, and persuasion. Though the literature on social networks and
health behaviors, including network interventions, has grown substantially, key populations and issues remain
under-investigated, such as networks of midlife adults, the impact of social selection (e.g., homophily) alongside
peer influence, and the equitable distribution of intervention effects. Further, given that network interventions
target small numbers of recipients and benefit larger numbers in a population, cost-efficiency is an important, yet
often neglected, metric of intervention success. The proposed study will address these research gaps by
conducting simulations to identify how workplace health behavior interventions can best capitalize on social
connections to have the most positive, equitable, and cost-effective impact on health behavior outcomes for
midlife adults. Our simulations will be built from a stochastic actor-oriented model (SAOM), a statistical network
model that simultaneously estimates the formation and dissolution of social ties alongside the transmission of
health behaviors. The model will be estimated using empirical data from prior studies testing the impact of a
healthy eating intervention employing social norms feedback and other behavioral nudges on the healthfulness
of employee cafeteria purchases within a workplace social network. We will map out the scenarios in which
interventions leveraging social networks have the most positive and equitable impact on employees’ healthy
purchasing. We will also assess how changing model parameters will shape intervention costs and cost-
effectiveness. Our specific aims are: 1) Develop, parameterize, and calibrate an SAOM simulating a network
including midlife employees (ages 50-64) within a socioeconomically diverse workforce based on empirical data.
2) Use the SAOM to manipulate the targeting strategy, effect size, durability, and social transmissibility of a
healthy eating intervention and run simulations to understand which characteristics of the intervention maximize
the healthfulness of employee food purchases. At the same time, we will assess the incremental cost-
effectiveness of alternate targeting strategies. 3) Across intervention targeting scenarios, use the SAOM to
manipulate aspects of social selection and heterogeneous peer influence by sociodemographic characteristics
to identify circumstances where interventions mitigate or exacerbate sociodemographic disparities in healthy
purchasing. Throughout, we will focus on employees in midlife (ages 50-64) embedded in this broader social
network. This work responds directly to RFA-AG-24-025 by modeling the impact of intervention, interpersonal,
and network characteristics across a range of scenarios to pinpoint effective, equitable, and cost-effective health
behavior interventions that can then be tested in more direct but more costly empirical randomized trials.

Public health relevance
PROJECT NARRATIVE Health behavior interventions introduced into social networks have the potential to efficiently improve population health by benefitting not just intervention recipients, but also those influenced by intervention recipients. However, the complex dynamics of social networks make it hard to predict the types of networks and network interventions where this approach will be most impactful, particularly for adults in midlife whose social networks are understudied. The current project will use simulation analyses based on real-world data from a workplace social network to identify the intervention strategies and network characteristics that yield the most positive, equitable, and cost-effective impact on health behavior outcomes for midlife adults.